Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core will manage Center activities and support the operational needs of two Biomedical Resource Cores – Biospecimens and Cell Models and Clinical Research. The Administrative Core will meet with Core Directors to prioritize the scientific direction of the research to accomplish the goals of the PKD RRC, coordinate our functions as part of the national consortium, promote communication with the CCS, RTCCs, and NIDDK to operate as a unified consortium, and promote internal and external collaborations. The Administrative Core will work with the Clinical Core to encourage EPOC patients to participate in Patient Engagement Group of the PKD RRC. Our Summer Student Research Program brings together students at different educational levels for a 10-week research and education training program. We focus on a Summer PKD Undergraduate Research Students (SPURS) program supporting up to 4 students and a volunteer program for local high school students. The aims are to (1) Oversee the vision and goals of the PKD Core Center, (2) Prioritize the distribution of resources to support the goals of the cores, (3) Review PKD Core Center activities and productivity, (4) Organize and oversee the educational enrichment program, and (5) Promote communication among the Central Coordinating Site, RTCCs, and NIDDK.

Public health relevance
The most common inherited disorder is autosomal dominant polycystic kidney disease (ADPKD), which is characterized by the formation and relentless growth of fluid-filled cysts in the kidneys, leading to tissue damage, inflammation, fibrosis and the loss of kidney function. The Kansas PKD Research and Translational Core Center established the Early PKD Observational Cohort Study to monitor cystic disease progression using MRI and collect clinical information and blood and urine biospecimens every year from children and young adults with ADPKD and assist researchers in the identification of novel biological markers that predict disease progression and monitor the response to clinical treatment. The Center also distributes tissues and primary cyst epithelial cells, obtained from ADPKD kidneys at the time of nephrectomy, to provide essential reagents for the investigation of therapeutic targets for human ADPKD and test novel drugs using relevant in vitro assays.